Center for Modeling Non-Coding Disease Variants: Preclinical/Co-Clinical Core

PROJECT SUMMARY/ABSTRACT: PRECLINICAL/CO-CLINICAL CORE
Mendelian conditions, in which variation of a single gene drives the disease phenotype, are a major disease
burden causing suffering and taxing the healthcare system. In recent years, increasing accessibility of exome
and genome sequencing has led to rapid increase in the number of gene-disease associations. Although these
advances have led to answers and treatments for many families with Mendelian diseases, 60-80% of cases with
a suspected genetic etiology remain unsolved. Current analysis strategies are optimized to find small coding and
splice junction variants but can be insensitive for non-coding and structural variants. While many bioinformatic
pipelines can robustly call non-coding variants, our ability to attribute them to Mendelian diseases is limited by
the paucity of data on their biological function. As a result, non-coding variants detected on clinical genomic tests
are often either filtered out due to inability to determine their consequence or reported to the clinician as variants
of uncertain significance. This knowledge gap limits our ability to diagnose conditions caused by non-coding
variants and identify biomarkers for variant resolution and therapy-development. A collaborative center to model
the impact of non-coding variants will accelerate the pace of disease-gene discovery, elucidate the disease
physiology, and identify molecular phenotypes that can be used as biomarkers for disease diagnosis and to
develop therapeutic interventions.
Our proposal leverages the broad clinical and research expertise of existing UCI rare-disease genomics
programs to create a Co-Clinical Core supporting a center for modeling non-coding variants in rare disease. This
core will collect high quality phenotype data to support variant prioritization and analysis, collect human tissues
for preclinical studies and storage, and facilitate return of results and future collaboration. This collaborative
approach will allow for integration of clinical and research grade human data with data from cell and animal
models to facilitate the discovery, diagnosis, and understanding of non-coding disease variants. The core will
function locally as well as globally as part of a network of precision modeling centers to collect standardized data
and contribute to network-wide protocols.